A Brief Family-Based Program to Bridge Youth on Probation to Trauma-Specific Treatment

Abstract
Youth involved in the juvenile justice system (YIJ) experience traumatic events and adverse
childhood experiences (ACEs) at disproportionately high rates, leading to posttraumatic stress
(PTS). When left untreated, YIJ’s PTS contributes to posttraumatic stress disorder (PTSD),
suicidal behavior, non-suicidal self-injury, and other disorders which factor into youth impairment
and the escalation of their justice system involvement. Recent legislative and policy trends have
led to an increasing number of YIJ residing not in detention, but instead under community
supervision (i.e., on probation). However, despite the existence of evidence-based treatments for
PTS in the community, YIJ on probation frequently do not receive the care they need, due to
complex, multi-level factors (e.g., cross-system coordination between behavioral health and
justice; long waitlists; lack of identification and appropriate referral; caregiver minimization of
youths’ problems; youths’ distrust of providers). There are promising, evidence-based protocols
to refer and link YIJ to community-based treatment services, however, these methods have not
yet been adapted to address YIJ PTS (e.g., through the incorporation of appropriate referral
pathways, or increasing youth motivation for, and caregiver support of, trauma treatment). This
K23 Award builds upon the candidate’s prior training and experience to fill critical gaps in the areas
of robust intervention development incorporating implementation considerations, expertise in
trauma sequalae and trauma treatment, and the design and evaluation of behavioral trials.
Additionally, this award will result in the development of T-Connect, a trauma-informed multi-level
intervention to bridge YIJ under community supervision to care for and increase youth and
caregiver engagement in YIJ’s trauma treatment. The research plan is divided into three phases,
which correspond to the candidates’ training objectives and research aims. First, the candidate will
conduct formative work with YIJ who have PTS, their caregivers, probation staff, and community-
based trauma treatment providers. Second, the candidate will develop, through established,
collaborative, community- engaged methods, an intervention (T-Connect) that integrates into
existing probation protocols to 1) refer/link YIJ in need of trauma treatment to appropriate care
and 2) increase youth and caregiver motivation for and support of treatment. Third, the candidate
will evaluate T-Connect through a randomized trial, comparing youth who receive T-Connect to
a services-as-usual control. The proposed training and research activities will take place at
Columbia University and be supervised by a team of NIMH-funded mentors.

Public health relevance
Project Narrative Posttraumatic stress (PTS), which is associated with mental illness (e.g., posttraumatic stress disorder, depression, anxiety, suicidal behavior, substance use, and oppositional defiant disorder), is alarmingly common among youth involved in the justice system (YIJ), including those under community supervision (i.e., on probation). YIJ on probation resides together in the community with their caregivers, and multi-level factors prevent them from accessing appropriate trauma-focused treatment including system- (e.g., cross-system linkage; long waitlists), family- (e.g., mistrust of providers; minimization of problems), and youth-level (e.g., stigma; previous experiences in treatment) barriers. This Mentored Patient-Oriented Research Career Development Award will develop T-Connect as a multi-level intervention to bridge youth on probation to trauma-focused treatment in the community, and increase motivation for treatment, while providing the Investigator with new expertise in the treatment of PTS, intervention development, and the implementation, evaluation, and design of behavioral trials.